IVOS Medical: Intubation, optimized.

Abstract
Endotracheal intubation (ETI) is a frequently used life-saving procedure performed daily. In the US alone, 15
million operating room intubations and 650,000 out-of-operating room intubations are performed annually. At
the initial outbreak of the SARS-Cov-2 pandemic of 2020, more than 70% of critically ill patients were intubated
and with new mutations, the increase in emergent intubation is only going to continue. Despite its frequency,
ETI is a high-risk procedure, with significant rates of respiratory complications, hemodynamic instability, and
cardiac arrest. Developed in the early 2000s, the video laryngoscope (VL) was created to assist with difficult
intubations vs the traditional practice by direct laryngoscopy (DL). This new method of intubation works by
means of a video camera on the distal end of the laryngoscope blade which is inserted into the mouth and
provides an indirect view of the vocal cords on a separate monitor. This widely-used tool for visualizing the
airway has garnered more acceptance as a first line tool for intubation in an emergent setting.The current
problem with intubation by means of video laryngoscopy is that they become virtually useless when the camera
view is obscured by bodily fluids, e.g., gastric contents and blood. IVOS Medical, LLC is a new medical device
startup developing an economical, disposable and novel video laryngoscope sleeve for maintaining clear vision
during breathing tube placement. The goal for our video laryngoscope apparatus is to elevate the current
safety profile of intubation by decreasing aspiration risk and the time an individual goes without oxygen, while
increasing intubation accuracy in patients who present with high risk of mortality. We believe our device will
benefit first responders and healthcare providers throughout our nations’ medical centers in particular
emergency departments, surgical suites and intensive care units. Preliminary testing in our Laerdal airway
manikin with our prototype IVOS Medical BOSS G4, has shown significant improvement of visual acuity after
clearing away simulated bodily fluids from the camera lens. Aims of this proposal are 1: Further development
of 3D printed IVOS Medical BOSS Glide 4 (G4) video laryngoscope sleeve and compare speed and efficiency
of successful intubation under aspiration conditions against the popular Verathon Glidescope AVL Blade 4,
among 60 medical operators. 2: Perform Finite Element Analysis (FEA) of the BOSS G4 sleeve. 3: Develop
and create 25 urethane injection molded samples of IVOS Medical Boss G4 laryngoscope sleeves. Phase II
will focus on design based on end user feedback, additional testing including on human cadavers. Analysis of
the suction capabilities to capture and remove potential airborne viral particles from the oropharyngeal space
can be investigated at this time. Furthermore, additional physical and materials testing will be performed to
reach the commercial-ready point at the end of Phase II. We believe that we can help save many lives affected
everyday as well as increase the safety net for other medical professionals performing this life saving
procedure.

Public health relevance
Narrative Endotracheal intubation (breathing tube placement) is a frequently used life-saving procedure performed daily. The current problem with intubation by means of video laryngoscopy is that they become virtually useless when the camera view is obscured by bodily fluids, e.g., gastric contents and blood. IVOS Medical, LLC is a new medical device startup developing an economical, disposable and novel video laryngoscope sleeve for maintaining clear vision during intubation.